Institutional Career Development Core

The purpose of the University of Pittsburgh KL2 Clinical and Translational Science (CTS) Scholars Program is
to provide individualized competency-based training by immersing scholars in multidisciplinary research
teams that will provide mentoring and intense experiences in the conduct of research from conceptualization to
completion. We will also help CTS scholars develop and submit competitive grant applications to transition to
independent investigators. To develop and promote the CTS scholars program we will take advantage of the
strong research training environment in the six Schools of the Health Sciences, especially the Institute for
Clinical Research Education (ICRE), which has a robust training infrastructure comprised of multiple degree
and career-development programs tailored to the needs of young investigators at every early career stage. The
ICRE also maintains a mentoring network, which includes 371 senior researchers from across the University
willing to serve as mentors to our Scholars. The KL2 has been highly successful in developing clinical and
translational scientists, of which many are already in leadership positions. This KL2 is a distinct program with
unique elements not found in other institutional K awards at the University, including a focus on individualized
training in core competencies, multidisciplinary team science, diverse disciplines and research experiences,
targeted seminars, and an emphasis on the entire spectrum of translational research. Our immediate objectives
for the proposed CTS Scholars program are to: recruit outstanding scholars with excellent training in their
content areas early in their research careers; train scholars in rigorous research methods to conduct
translational research; enhance skills in grant writing, team science, leadership, stakeholder engagement, and
entrepreneurship; guide scholars in asking important translational research questions and implementing
research projects to answer them; and ensure close mentoring to guide research career development. Our long-
term objectives will be to: ensure that Scholars complete their translational research studies on time; help
scholars use these studies to propose large-scale projects and obtain independent funding; facilitate scholars'
ability to serve as mentors and leaders in translational science; develop resiliency and skills at self-care so that
Scholars maintain a successful research career. Our goal is to recruit a diverse pool of Scholars, support them
throughout their career, and evaluate and track their success over time.